Intraoperative quantitative CT imaging of breast specimen for reducing re-surgery rate and tumor cataloguing

Project Summary/Abstract
The objective of the project is to develop the world-first X-ray dual-energy cone-beam microCT (DECB µCT)
dedicated to intraoperative imaging of lumpectomy specimen for improving positive margin identification (PMI)
and thus re-call rate for re-surgery in breast conserving surgery (BCS). Breast cancer remains the leading
cancer among women in the US, BCS is used as part of the BC treatment for majority of the cases. In BCS,
the specimen of negative margin containing tumor is excised with a minimum rim of normal fibroglandular (FG)
and adipose tissues, as opposed to removal of the entire breast in mastectomy. Positive margins (PM), i.e.,
breast cancer (BC) close to, or on, the specimen edge, if missed, can lead to a high re-surgery rate. While the
BC-adipose tissue contrast can be high, the BC-FG tissue contrast remains low in standard X-ray imaging.
Therefore, it is critically important to develop intraoperative imaging techniques to differentiate BC and FG
tissues during the BCS. Our DECB µCT, enabled with innovative algorithms for image reconstruction and
analysis, can yield 3D volumetric specimen images with enhanced BC-FG contrast that can directly improve
intraoperative PMI and minimize missed PMs. It thus addresses the need to reduce the BCS recall and re-
surgery rates. The specific aims of the project are (1) To develop DECB µCT for quantitative lumpectomy
specimen imaging; (2a) To acquire highly-sampled DECB µCT of invasive ductal/lobular carcinomas
specimens; (2b) To optimize and adapt scan designs of the DECB µCT to BCS clinical workflow; and (3) To
evaluate the DECB µCT using patient specimens and to compile a tumor database. The project is built upon
our previous success in the development and clinical application of single-energy cone-beam (SECB) µCT,
and a key outcome of the project is that we will have established the feasibility of DECB μCT for yielding
enhanced BC-FG tissue contrast for improving intraoperative-PMI with AUC of ∼0.95 or higher, thus leading to
a reduction of the current BCS re-surgery rate. The first database of quantitative images and their
histopathological analysis data of breast malignant tissues will also be created that provides unprecedented
amount of detailed information about breast normal and tumor tissues valuable to the development of machine
learning (ML)-/deep learning (DL)-based methods for automated intraoperative-PMI in BCS and to the
fundamental understanding of BC characteristics for advancing breast cancer research and applications.

Public health relevance
Project Narrative Breast conserving surgery is used as part of the treatment of breast cancer, the leading cancer among women in the US, in which the lumpectomy specimen containing breast cancer is excised with a minimum rim of normal tissue. If the breast cancer close to the specimen edge, referred to as the positive margin, is missed during the surgery, it can lead to a high rate of re-surgery. We develop an X-ray dual-energy cone-beam microCT technology for point-care, intraoperative positive-margin identification, allowing for reduction of re- surgery rate in breast conserving surgery and for tumor cataloguing in breast cancer research and treatment.